MECHANISM AND CONTROL OF INTESTINAL CALCIUM TRANSPORT

The contribution of intestinal calcium transport to whole-body calcium homeostasis is well recognized but the details of the control of calcium absorption together with a quantitative appreciation for the role of regional calcium input through the intestine have not been clearly identified. Vitamin D stimulates intestinal calcium absorption but the relative roles of active and passive calcium fluxes in large and small intestine have received very little detailed attention. The role of the large intestine has been virtually ignored until very recently. Combining both biochemical and biophysical techniques to the study of intestinal calcium transport, it is hoped that the proposed research will identify the mechanisms responsible for transepithelial cellular calcium transport. The role of ion transport pumps at the level of the plasma membrane will focus a large fraction of the investigation. The interaction of these membrane-oriented pumps with vitamin D, regulatory ions such as calcium, and cytoplasmic regulators such as calmodulin and cyclic nucleotides will be studied in detail. Such investigations may increase our understanding of not only intestinal calcium transport but also the role of calcium in the control of absorption and secretion of electrolytes such as chloride and sodium together with associated water movements. Investigation of the cellular pathway for calcium absorption will be continued with in vitro rat large intestine (cecum). Investigation of the coupling of verapamilsensitive calcium entry at the apical cell pole with calcium efflux at the basolateral cell membrane via Ca-ATPase and Na:Ca exchange should provide increased understanding of intestinal calcium transport and its relation to cellular calcium homeostasis. The capacity to isolate specific transport components in the analysis of these problems represents a new and relative unexplored area of investigation for the intestine.